PHARMACOKINETIC STUDY OF BCNU AND TEMOZOLOMIDE IN PATIENTS WITH CNS TUMORS

To estimate the maximum tolerated dose of the combination of temozolomide and BCNU in patients with central nervous system (CNS) or systemic tumors refractory to standard therapy; to characterize the dose-limiting toxicity and other toxicities of this combination when either temozolomide or BCNU is given first; to characterize the pharmacokinetics of temozolomide and any sequence effects on the pharmacokinetic parameters of temozolomide; and, to identify any preliminary evidence of anticancer activity in treated patients.